PREVENTING CHILDHOOD INJURY WITH AN INTERACTIVE WEB SITE

Scientific evidence indicates risk factors associated with passenger, bicycle, and pedestrian safety behavior account for the majority of roadway accidents resulting in death or injury to children 7 to 12 years of age. In the majority of these deaths and injuries, the child's behavior contributed to the injury (e.g. failing to wear a bicycle helmet, darting out into traffic, failing to wear a seat belt, etc.). An innovative, engaging, interactive Web site with games, activities, and a simple animated story line, when combined with the behavioral model of observation, coaching and feedback, could teach the behaviors integral to passenger, bicycle, and pedestrian safety. In Phase I, a prototype Web site with companion print materials will be developed and evaluated systematically using a qualitative and iterative methodology. The Web-based tool will be evaluated in focus groups and in-depth interviews by children, parents, and school curriculum coordinators. In Phase II, evaluation of the prototype will be expanded to include a quantitative comparative study to examine the impact of the Web site on outcome measures of safety knowledge and safety behaviors and ultimately on incidence of bicycle-, pedestrian- and passenger-related injury. PROPOSED COMMERCIAL APPLICATION: The goal of this Phase I proposal is to develop an innovative, interactive Web-based tool to teach roadway safety to children. This web-based tool would have companion print materials and be designed to complement a school curriculum focused on health and safety. Our partner, Arbella Mutual Company, has a history of supporting health promotion and roadway safety projects and has demonstrated an interest in promoting and disseminating a Web site application to address the safety needs of children.